2024 Biomarkers of Aging Conference

PROJECT SUMMARY
This application requests funds to support the 2024 Biomarkers of Aging Conference, which will be held from
November 1–2, 2024 at the Joseph B. Martin Conference Center at Harvard Medical School in Boston,
Massachusetts. This conference has been organized by the Biomarkers of Aging Consortium following the
success of our inaugural event in 2023. We again aim to bring together many stakeholders who work on all
aspects of aging biomarkers. Although tremendous strides have been made in the development of aging
biomarkers, none have been systematically validated. Moreover, there is little consensus within the ﬁeld on how
such biomarkers may best be developed, validated, and deployed. This represents a major hindrance in the
translation of these tools from preclinical studies to clinical trials to test the ability of geroprotectors to extend
healthy lifespan. The annual Biomarkers of Aging Conference is a key initiative organized by the consortium in
parallel to ongoing scholarly work and other projects. We envision this conference as the premier yearly venue
for scientists working on aging biomarkers to meet and discuss the most pressing issues in the ﬁeld, a need
evidenced by the overwhelming response to our inaugural 2023 symposium. We strongly feel that a coordinated
and ongoing effort will be necessary to realize the promise of the burgeoning aging biomarkers ﬁeld in improving
the lives of aged individuals across the world. To support this goal, we have organized this year's conference
with the goals of: (1) disseminating the latest research related to aging biomarkers to a broad audience through
scientiﬁc presentations; (2) considering critical outstanding issues that are impeding the ﬁeld from moving
forward and identifying concrete steps to meet these challenges; (3) providing a unique forum for networking
between academic scientists, clinicians, regulatory experts, and representatives from industry; and (4)
supporting the career development of junior scientists, particularly those from backgrounds underrepresented in
science, through active participation opportunities and cultivation of an environment that encourages interactions
with senior experts in the ﬁeld. We believe we have organized a strong program which will directly support the
consortium's broader goal of enabling the establishment of reliable biomarkers of aging for clinical use. We feel
that this conference will be useful to the community and will continue to serve as an important annual event for
all those working to bring biomarkers of aging to the clinic to improve human lives.

Public health relevance
PROJECT NARRIATIVE The 2024 Biomarkers of Aging Conference will bring together leading experts working on all aspects of aging biomarkers. These critically important tools quantitatively assess the aging process are needed to test the ability of geroprotective interventions to extend healthy lifespan. The conference will focus on consensus building within the ﬁeld to establish standards for the development, validation, and clinical application of biomarkers of aging.